Histone Acetylation Dynamics and Epigenome Duplication

Eukaryotic genomes exist in a complex and dynamic 3-dimensional structure that provides important regulatory
information controlling gene expression programs essential for the maintenance of cell identity. Genome
structure is also critical for packaging the genome in the nucleus and preserving genome stability. Genome
structure is primarily dictated by its' association with the histone proteins to form chromatin. The post-
translational modifications on histones play a key role in determining genome structure as they regulate the
association of non-histone proteins with genomic DNA. An important challenge for eukaryotes is the
epigenetic inheritance of the histone modification patterns that govern genome structure following DNA
replication and cell division. This proposal seeks to identify fundamental mechanisms that regulate the
epigenetic inheritance of histone modification patterns.
Following passage of a replication fork, newly replicated DNA is packaged into chromatin that contains a 1:1
mixture of parental histones and newly synthesized histones. The retention of modification patterns on
parental histones provides the spatial memory for the duplication of specific chromatin states. The key step in
epigenetic inheritance is the transfer of the parental modification patterns to the neighboring new histones.
Our work is based on the hypothesis that the new histones play a critical regulatory role in the epigenetic
inheritance of chromatin states. The current proposal is based on my lab's identification of previously unknown
links between the dynamic acetylation of newly synthesized histones and the epigenetic inheritance of specific
chromatin states and the restoration of 3-dimensional genome architecture following DNA replication. The
experiments proposed here will characterize the effect of new histone acetylation on the structure and
composition of chromatin and identify factors and pathways that function with new histone acetylation to
regulate the epigenetic inheritance of chromatin states. In addition, we will characterize a previously
unanticipated role of new histone acetylation in the epigenetic inheritance of 3-dimensional genome
architecture through regulation of the interactions between chromatin and the nuclear lamina.

Public health relevance
The successful duplication of a cell's genome involves replication of both the sequence of the DNA and the structure of the genome. Errors in either of these aspects can result in numerous human diseases. The goal of this proposal is to define how dynamic histone acetylation regulates the epigenetic inheritance of genome structure.